AGE RELATED CHANGES IN STEREOSELECTIVE DISPOSITION OF PROPRANOLOL

Effect of age and gender on the pharmacokinetics of the enantiomers of propranolol are being studied. Racemic propranolol is given orally and the pharmacokinetics of the separate enantiomers determined.